Functional Dissection of the K27M Histone Mutation In Gliomagenesis

? DESCRIPTION (provided by applicant): Diffuse Intrinsic Pontine Glioma (DIPG) is an incurable type of brain cancer that arises in children. Recently genomic studies unraveled that a subset of human DIPGs harbor activating mutations in ACVR1 and K27M H3.1 mutations. Here we will study the mechanisms by which ACVR1 mutations and K27M H3.1 mutations cooperate in brainstem gliomagenesis.

Public health relevance
PUBLIC HEALTH RELEVANCE: This Research Project Grant (R01) award will support Dr. Becher to use mouse genetics to study the mechanisms by which ACVR1 mutations cooperate with the K27M H3.1 mutation to promote diffuse intrinsic pontine glioma (DIPG) pathogenesis. These in vitro and in vivo studies will provide a mechanistic foundation for the design of safe and effective therapies to treat this incurable brain cancer that arises in children.